Type III Secretion Translocon Structure and Function

DESCRIPTION (provided by applicant): P. aeruginosa is a common cause of hospital-acquired infections. It uses a type III secretion system to directly inject effector proteins into targeted host cells, in particular neutrophils, thereby preventing clearance by the host immune system. Injection of effector proteins involves a specialized structure called the translocon, which consists of a pore in the host cell membrane that interacts with the tip of the type III secretion needle. While the translocon is critical for type III secretion function, it has been difficult to study biochemically. Here we propose to use a genetic technique to identify critical translocator interactions and categorize them according to their function in the translocation process (translocator insertion, pore formation, docking of the tip to the pore and triggering of effector secretion). Identifying translocator contacts that are critical for function not only increases our understanding of the translocon, it also identifies potential targets for therapeutic intervention that lie outside of the bacterial cell and are therefore not shielded by conventional antibiotic resistance mechanisms, such as the outer membrane or efflux pumps.

Public health relevance
PUBLIC HEALTH RELEVANCE: P. aeruginosa is a common cause of hospital-acquired disease with a high rate of mortality. It uses a molecular syringe to inactivate the patient's immune system. We are proposing to study the function of a critical component of this syringe, which lies on the outside of the bacterial cell and therefore represents an attractive target for drug development.